Stress and Subclinical Cardio-Metabolic Disease in Police: A Longitudinal Study

DESCRIPTION (provided by applicant): Certain characteristics of police work such as shift work, long work hours, high demands, and traumatic exposures have been associated with increased levels of psychological stress and in some cases with adverse cardiovascular outcomes. An observational study conducted over a period of time can provide more convincing evidence that these workplace stressors lead to development of adverse physiological and psychological health outcomes. Thus, the general objective of this project is to conduct a longitudinal follow-up assessment of approximately 475 police officers for whom baseline data and a protocol infrastructure have already been established. The study will assess police workplace stress by examining physiological and psychological measures of stress and evaluating potential associations of these measures with subclinical markers or early signs of cardiovascular and metabolic disease in a population-based design. Markers of disease include blood pressure; laboratory measurement of lipids, glucose, and insulin; heart rate variability to assess autonomic nervous system function; ultrasound imaging studies to measure carotid artery wall thickness (atherosclerosis) and brachial artery reactivity (endothelial or vascular function); and dual-energy x-ray absorptiometric (DXA) measurement of body fat, lean tissue composition, and bone density. Also to be examined are psychosocial factors known to be detrimental to health such as perceived stress, depression, and hostility, and factors known to be protective (e.g., resiliency and social support). The research findings on the health consequences of stress can be translated into improved prevention practices. Analysis of the complex prospective data acquired from this research may contribute to a better understanding of how exposure to stressors over time may lead to early indicators of cardiovascular and metabolic abnormalities. According to the National Institute for Occupational Safety and Health, the percentage of workers who describe their job as very or extremely stressful can be as high as 40 percent (Stress...At Work; NIOSH Publication No. 99- 101). Given this likelihood that stress is relatively common in the workplace, prevention of adverse health consequences that may be associated with stress could benefit a large proportion of the working population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Stressors inherent in police work and related lifestyle factors have been associated with adverse cardiovascular and metabolic health outcomes. However, the majority of studies has thus far been cross sectional in design, and has focused mostly on apparent clinical outcomes. Thus, the overall goal of this project is to longitudinally examine the impact of occupational stressors on early signs of cardiovascular and metabolic disease in police officers in order to further knowledge on this topic and enhance prevention efforts in the field. Project Narrative Stressors inherent in police work and related lifestyle factors have been associated with adverse cardiovascular and metabolic health outcomes. However, the majority of studies has thus far been cross sectional in design, and has focused mostly on apparent clinical outcomes. Thus, the overall goal of this project is to longitudinally examine the impact of occupational stressors on early signs of cardiovascular and metabolic disease in police officers in order to further knowledge on this topic and enhance prevention efforts in the field. __SpecificAimsTextDelimiter__ Specific Aims Our goal is to conduct a longitudinal study of a unique, already established Police cohort with detailed baseline clinical and epidemiological assessments. The aims will determine whether exposure to police work is associated with adverse physiological and psychological health outcomes. Specifically, we propose to determine whether the stressors associated with police work assessed at baseline predict progression of subclinical cardiovascular disease (CVD), metabolic derangement and psychological disorders over a 5-year period. The proposed study will address nine of the 28 Focus Areas (diabetes, heart disease and stroke, injury and violence prevention, mental health and mental disorders, nutrition and overweight, occupational safety and health, physical activity and fitness, substance abuse, tobacco use) and 5 of the 10 Leading Health Indicators (physical activity, overweight and obesity, tobacco use, substance abuse, mental health) in the U.S. Department of Health and Human Services Healthy People 2010 (http://www.healthypeople.gov). Additionally, the proposed study addresses two areas of the Centers for Disease Control and Prevention's Health Protection Goals: Healthy People in Every Stage of Life (Adults age 20-49 and Older Adults and Seniors age 50 and older) and Healthy People in Healthy Places: Healthy Workplaces (http://www.cdc.gov/LifeStages). The following National Institute for Occupational Safety and Health's National Occupational Research Agenda sector and cross-sector strategic goals will be addressed (http://www.cdc.gov/niosh/programs): a) Services and Public Safety Sub-Sector - Law Enforcement Strategic Goals: 8.1.2 - By 2012, develop and validate biomarkers for occupational stress associated with CVD among law enforcement officers, 8.1.3 - By 2013, conduct etiologic studies of occupational risk factors and CVD in law enforcement officers, and 8.1.5 - By 2013, evaluate the association of work organization factors such as job classification, shift-schedule, and overtime on cardiovascular risk and cardiovascular events; b) Work Organization Cross Sector Strategic Goal 1.3 - Conduct laboratory and workplace studies to identify work organization risk factors for stress, illness, and injury; and c) Cancer, Reproductive and CVD Cross-Sector Strategic Goals: 4.1.1 - Conduct analytic epidemiology studies of high-priority, high-feasibility populations to identify and quantify risk of CVD associated with workplace exposures, and 4.1.2 - Use established/new biomonitoring methods to assess the association of workplace factors and exposures with sub-clinical/clinical CVD in workers. Specific Aim [1: Reexamine the Buffalo Cardio-Metabolic Occupational Police Stress (BCOPS) Study cohort and conduct data analyses to address longitudinal and cross-sectional hypotheses] (Figure 1). Hypothesis #1: Exposure to police work (e.g., shift work, extended hours, traumatic events) is associated with adverse changes in subclinical CVD (e.g., increased carotid intima media thickness (CIMT), decreased flow-mediated dilation (FMD)), metabolic derangement (e.g., development of metabolic syndrome) and psychological disorders (post-traumatic stress disorder (PTSD) and depression). Hypothesis #2: Exposure to police work is associated with a) a worsening of hypothalamic-pituitary- adrenal (HPA) axis function, as indicated by adverse salivary cortisol response patterns; b) diminished sleep quantity and quality; and c) adverse changes in vascular markers of inflammation, hemostasis and metabolic status. Hypothesis #3: HPA-axis dysregulation, diminished sleep quantity and quality, and adverse changes in vascular markers of inflammation, hemostasis and metabolic status are associated with adverse changes in subclinical CVD, metabolic derangement and psychological disorders. Based on the above results, we plan to assess whether associations observed under Hypothesis #1 are mediated by HPA-axis dysregulation, diminished sleep quantity and quality, and markers of inflammation, hemostasis and metabolic status. Hypothesis #4: Measures of exposure to police work, some assessed for the first time at the follow-up examination such as job strain, are associated cross-sectionally with adverse levels of subclinical CVD (e.g., ankle-brachial index (ABI), FMD, HRV). Specific Aim [#2]: Translate and communicate study findings to relevant audiences and stakeholders. Sub Aim 2.1: Communicate results and study findings through peer-reviewed publications and/or trade/lay publications. Sub Aim 2.2: Communicate and provide recommendations to stakeholders, including other inter-disciplinary researchers, police officers, law enforcement agencies, unions, the medical community, mental health professionals, and other emergency responders. By successfully addressing our specific aims and hypotheses, our proposed prospective study will provide knowledge that is likely to lead to recommendations on how best to improve the health consequences of workplace stress among the law enforcement community. Figure 1. Associations to Examine in Proposed Prospective Study of Buffalo Police Officers Work-Related Exposures Shift Work, Extended Work Hours, Traumatic Events, Perceived Stress, Years of Police Service 1 2 HPA-Axis Dysregulation, Diminished Sleep Duration and Quality, Adverse Levels and Changes in Markers of Inflammation, Hemostasis and Metabolic Status 3 Health Outcomes Subclinical Cardiovascular Disease: Increased Carotid IMT, Decreased Flow-Mediated Dilation, Increased Left Ventricular Mass, Decreased Ejection Fraction, Decreased Heart Rate Variability Metabolic Derangement: Glucose Intolerance, Metabolic Syndrome Psychological Disorders: Depression, PTSD